Admin. Supp.: Correction of Neurological Disease via Allele Specific Excision of Pathogenic Repeats

PROJECT SUMMARY / ABSTRACT
A central promise of genome editing is its potential to treat monogenic disease. Despite early-stage clinical
progress for CRISPR-Cas based approaches, monogenic neurodegenerative conditions and nucleotide triplet
expansion disorders have not been a focus of any biotechnology company in this space. Our proposal brings
together a team of academic investigators to develop a synergistic suite of first-in-class CRISPR-Cas based
therapeutics for Huntington's disease (HD) and C9ORF72 amyotrophic lateral sclerosis (ALS). We will engineer
and deploy an editing approach that excises, with IND-grade potency and mutant allele-selectivity, the disease-
causing expansion repeat from human HTT and C9ORF72 loci, respectively. Our strategy is based on identifying
alleles of commonly heterozygous SNPs that reside on the same haplotype as the disease-causing repeat
expansion, and then engineering CRISPR-Cas9 for high selectivity of cleavage, on one or both sides of the
mutant allele repeat, to drive its excision, with two tiers of delivery innovation. Our trailblazer project (Research
Project 1, RP1) will develop an HD therapeutic by packaging mutant HTT-specific CRISPR-Cas9 into a newly
developed serotype of adeno-associated virus (AAV) with robust and broad biodistribution in the brain
parenchyma of nonhuman primates (NHP). We will implement an innovative strategy in which the CRISPR-Cas9
cassette temporally limits its own expression. We will identify and advance the preclinical lead composition
through IND-enabling studies leveraging 3 dedicated Resource Cores to (i) assess molecular outcomes at the
genetic level, (ii) administer reagents to animals and observe their behavior, and (iii) assess molecular and
histological outcomes from cells and animal tissues. An Administrative Core led by experienced developers of
genome editing-based therapeutics, will provide project-management support and lead on preparation of
regulatory submissions, aiming to file an HD IND by program end. In RP2, we will apply the AAV-based excision
approach to build a cognate experimental therapeutic for C9ORF72-driven ALS. Synergies with RP1 include
CMC innovation to manufacture novel AAV, re-use of the self-regulating CRISPR-Cas cassette and virus
harboring it, and regulatory feedback on IND-enabling pharmacology, toxicology, and biodistribution studies. We
will advance RP2 through pre-IND. For RP3, we will establish a first-in-class, transformative paradigm for in vivo
genome editing therapy by reformulating the preclinical lead CRISPR-Cas9 combination used in RP1 into a
highly innovative “Cas9 RNP monoparticle” in which amphiphilic peptides deliver the gene editor to neurons
upon injection. We will develop approaches for monoparticle manufacture to enable ex vivo and in vivo efficacy
studies in HD models. Extensive synergies with RP1 project and comprehensive support by the RCs will enable
us to advance this approach to pre-IND by program end. The sum total of this effort will establish a fundamentally
new paradigm for in vivo genome editing applicable to all nucleotide repeat expansion disorders, and advance
preclinical lead formulations for one disease, HD, to IND, and another such disease, C9ORF ALS, to pre-IND.

Public health relevance
PROJECT NARRATIVE Neurodegenerative diseases resulting from nucleotide triplet expansions, such as HD and ALS, lack any disease-modifiying therapy. We will establish a first-in-class paradigm for the use of in vivo gene editing for these diseases - allele-specific excision of the disease-causing expansion - and reduce it to preclinical and regulatory practice. To this end we will (i) develop a mutually synergistic suite of CRISPR-Cas9 preclinical leads for both mutant HTT and mutant C9ORF92; (ii) using multiple innovative viral and nonviral delivery formulations, perform IND-enabling preclinical pharmacology, toxicology, CMC, and biodistribution studies; (iii) advance an AAV-formulated CRISPR-Cas approach for HD to IND, and for ALS - to pre-IND.